Immunology and Infectious Diseases Training Program

The goal of the Immunology and Infectious Disease Training Program (IIDTP) at Indiana University School of
Medicine is to develop diverse, multi-faceted scientists capable of responding to the nation's health and
educational needs in the areas of host immunity and infection. Advanced knowledge of the immune system
and infectious agents is essential given their impact on an increasing number of issues in human health
including metabolic, vascular and cardiac diseases, aging, neural disorders, and cancer. This renewal
application seeks continued support for years 16-20 of the IIDTP with three primary components of the training
program. The first component is support of three pre-doctoral fellows, the second is support of two postdoctoral
fellows, and the final component is the support of four short-term trainees (medical students) for summer
research experiences, all within an interactive, multi-disciplinary medical center environment. Institutional
support for the IIDTP is considerable and includes financial support for trainee education and program
direction, administrative support, and state of the art facilities for basic and translational research. The IIDTP
unites thirty-one faculty in a highly developed infrastructure that includes training opportunities for the
development of multiple skills needed for a successful career in science. Strengths of the program include the
highly collaborative research of the faculty, an established program for mentoring at all levels, an extensive
track record of relevant, quality publications from mentors and trainees, program mentors' sustained
acquisition of extramural research funding, and successful placement of trainees in relevant careers including
academics, medicine, government, and industry. Comprehensive training is offered through didactic courses
including bioethics, research seminars and conferences, program-specific journal clubs and meetings, grant
and career workshops, and face-to-face faculty mentoring. The program is directed with careful consideration
of trainee progress and mentor success. Altogether, this active and successful training program remains
poised to prepare trainees for central roles in health and education-related professions.

Public health relevance
This T32 renewal application supports Immunology and Infectious Diseases Training for predoctoral students and postdoctoral fellows, and short-term research experiences for medical students at Indiana University. This is a unique training program in the state and provides the training infrastructure for thirty-one program faculty and over 100 trainees.